Long-Term Effects of COVID-19 on Cognitive Function and Mental Health

The ongoing pandemic of COVID-19 continues to have a detrimental impact on society, even after the
rapid development of safe and effective vaccines. The worst phases of the pandemic caused systemic
and cultural shifts in education, work, commerce, social ties, and even the process of grieving. The
SARS-CoV-2 virus has taken 6.5 million lives worldwide, over 1 million lives in the US, and nearly 23,000
Veterans receiving care in the VA system. The highly infectious Omicron variant has caused the largest
surge of cases yet, with a peak in mid-January 2022. This variant causes milder symptoms but is more
resistant to current vaccines. While the most severely affected COVID patients are rightfully the focus
of many investigations, patients with milder disease may show lasting changes as well. An important
study by Al-Aly, Xie, and Bowe (2021) identified all non-hospitalized Veterans who had at least one
SARS-CoV-2 positive test and who survived 30 days after diagnosis. Six months later, those who had
COVID had an excess burden of respiratory conditions, metabolic disorders, cardiovascular conditions,
insomnia, fatigue, anxiety disorders, trauma-related disorders, and neurocognitive disorders. Follow-up
studies found that many of these conditions can persist for at least one year (Xie et al., 2022a,b). In
addition, the risk of adverse health outcomes increases in Veterans with multiple infections (Al-Aly et al.,
preprint). Although epidemiological studies have been helpful in identifying population-level trends, a key
missing perspective can be provided by Veterans’ ratings of their own mental and physical symptoms.
This is critical because future interventions require a deeper understanding of the challenges faced by
Veterans with post-COVID conditions. The unique needs of Veterans include higher rates of the
comorbidities commonly associated with a greater risk of negative COVID outcomes (diabetes,
hypertension, and cardiovascular conditions). Ongoing cognitive issues after a COVID infection can also
have a negative impact on employment and daily functioning. Cognitive dysfunction was the third most
commonly reported symptom in a survey of the Long Covid community (Davis et al., 2021), yet "brain
fog" remains scantly investigated, especially in Veterans. The proposed observational study will have a
two group, prospective, repeated measure (3 time points) design with a study group and a closely
matched healthy comparator group. The study group will be Veterans (n=300) who had a positive test for
SARS-CoV-2 within the last 3-24 months but were not hospitalized. This population comprises the
majority of VA patients with positive tests for SARS-CoV-2 (approximately 85-90%). Their results will
be compared to healthy Veteran controls matched on demographic variables, pre-existing psychiatric
conditions, and major comorbidities (n=300). Follow-up tests will be conducted six months and 12
months later. The project will obtain objective measures of cognitive performance over time and
explore their relationship to mental health (anxiety, depression, PTSD) and other persistent post-acute
sequelae of SARS-CoV-2 (PASC) symptoms (insomnia, fatigue) in COVID-19 survivors. Covariates will
adjust for baseline scores, number of vaccines, and time since diagnosis. We will also examine the
impact of multiple infections on mental health and cognitive outcomes. A validated web-based testing
platform will obtain objective and reliable measures of sustained attention, executive function, episodic
memory, and working memory. A better understanding of specific weaknesses in cognitive function over
time is necessary to identify future intervention targets in the Veteran population with persistent post-
COVID conditions. Our study will also establish the importance of monitoring the mental health of
Veterans who have recovered from COVID-19. Those with persistent symptoms can be referred to
appropriate services to improve their quality of life.

Public health relevance
The burden of COVID-19 on survivors and health care systems is greater than we imagined. Most Veterans recover from the illness, but a considerable number have lingering symptoms that affect mental health and sleep. Cognitive problems are commonly reported in post-acute COVID-19, with a substantial impact on social and occupational function. Yet self-reported “brain fog” appears to be an under- investigated outcome. A distinct gap in the literature to date is objective cognitive testing in Veterans who had a positive test for COVID-19. The current project will use a web-based platform to directly assess cognitive function over time and its relationship to mental health in COVID survivors. Determining which factors are most associated with the negative consequences of compromised cognitive function post- COVID is a critical question not yet addressed by current studies. The results will have important implications for Veterans and the VA, especially since new variants of the virus will appear in the future.